Addressing Mental Health Comorbidities: Integrated CBT to Improve Functioning in Veterans with Co-Occurring Anxiety and Substance Use

Background and significance: Co-occurring hazardous drinking and mental health disorders, particularly
anxiety disorders, is an especially problematic combination experienced by deployed Veterans. Although VA is
a leader in delivering evidence-based mental health treatment, gaps remain in our understanding of how to
best promote psychosocial recovery for Veterans with co-occurring anxiety and hazardous drinking. Veterans
who have been deployed are at particular risk for experiencing problems in functioning and reintegration
related to mental health disorders and alcohol use. Co-occurring anxiety, posttraumatic stress disorder
(PTSD), and hazardous drinking heavily impact psychosocial functioning (including occupational and
relationship functioning) and quality of life. Cognitive behavior therapy (CBT) is an evidence-based
psychotherapy (EBP) for anxiety disorders and hazardous drinking that can promote improvements in
functioning and quality of life. However, many Veterans do not receive CBT for anxiety disorders and/or SUD.
A significant challenge in treating an anxiety disorder or SUD with CBT is that providers most often treat each
disorder separately, often in separate clinics. This results in an inefficient treatment process that leads to poor
outcomes. The Unified Protocol (UP) is a transdiagnostic CBT protocol that effectively treats symptoms of
multiple emotional disorders simultaneously. Adapting the UP to meet the needs of deployed Veterans with co-
occurring anxiety, PTSD, and hazardous drinking has the potential to more efficiently and effectively improve
functioning and reduce symptoms. Given the impact of anxiety, PTSD, and hazardous drinking among
returning Veterans, the research goals of this RR&D CDA-2 proposal support the adaptation of the UP for use
among deployed Veterans with hazardous drinking and examination of its feasibility, acceptability, and
preliminary efficacy. Research Plan: Aim 1: Adapt the UP for treatment of anxiety disorders/PTSD and
hazardous drinking among deployed Veterans (UP-A). This will be achieved using established iterative
intervention development strategies, including incorporating stakeholder feedback in the development of the
intervention. Feedback from stakeholders will include qualitative interviews key stakeholders (clinicians,
Veterans). Aim 2: Evaluate deployed Veterans’ experience using UP-A through a non-randomized pilot trial (N
= 10) and qualitative interviews with Veterans and revising the intervention based on findings to ensure
Veteran-centricity, Veteran satisfaction, feasibility, and acceptability. Veterans will be recruited from VA
treatment settings and provided UP-A by study clinicians. Veterans will complete measures of functioning and
symptoms before and after receiving the intervention. Aim 3: Explore the feasibility, acceptability, and
preliminary effect of UP-A on functioning outcomes, anxiety and PTSD symptoms, and alcohol use through a
pilot randomized controlled trial. Deployed Veterans (N=40) will be randomized to receive UP-A or a problem
solving therapy control. Outcomes will be collected at baseline, post-treatment, and three months post-
treatment. Veterans will also complete qualitative interviews to obtain feedback on feasibility and acceptability.
Career Plan: Dr. Ecker will receive training in conducting rehabilitation research among high-need Veteran
populations (e.g., post-deployment health), clinical trial research, and training related to becoming an
independently-funded VA researcher. These training objectives will be achieved through a multifaceted
strategy that includes research with mentors, formal coursework, trainings/seminars/conferences, and
consultation with the mentor team. Training will support the immediate goals of successfully conducting the
proposed research and the long-term career goal of conducting research to improve functioning in Veterans
with complex mental health care needs.

Public health relevance
Co-occurring hazardous drinking, anxiety disorders, and PTSD are problematic combinations of mental health concerns experienced by deployed Veterans. Veterans who have been deployed are at particular risk for experiencing problems in functioning and reintegration related to mental health disorders and hazardous drinking. Co-occurring anxiety and hazardous drinking heavily impact psychosocial functioning and quality of life. Although cognitive behavior therapy (CBT) can promote psychological recovery through improvements in functioning and quality of life, most CBT protocols do not address co-occurring disorders, leading to inefficient and disjointed treatment. The current research seeks to adapt and test the Unified Protocol (UP) for deployed Veterans with hazardous drinking. The use of combined CBT for both anxiety disorders and hazardous drinking has the potential to more efficiently and effectively improve functioning, reduce symptoms, and promote psychosocial recovery.